To provide marketing and outreach for the NIAAA SBIR/STTR program to help communicate the objectives of the program.

To provide marketing and outreach for the NIAAA SBIR/STTR program to help communicate the objectives of the program.